DP24-004, PRC Core: Dissemination and implementation of a community-driven approach to improve the health of women, infants, and families

PROJECT SUMMARY/ABSTRACT
Women and birthing people who identify as African American are more likely to experience severe maternal
morbidity or mortality or deliver a low-birth weight infant and experience hypertensive disorders of pregnancy at
higher rates. Factors leading to health disparities around chronic disease such as hypertension, cardiovascular
disease, and diabetes are set early in life: the long-term effects of health disparities in pregnancy and early
childhood signal that interventions at this time of life may have a positive impact on adult health and chronic
disease. The lived environment and socioeconomic status have a larger impact on outcomes than health
behaviors and clinical care, so advancing effective prevention strategies that eliminate deleterious social
determinants of health is an urgent priority. The overarching mission of the University of Wisconsin-Madison
Prevention Research Center (UWPRC) is to improve the health of women and birthing people, infants, and
families impacted by health inequities, by conducting and building capacity for high-quality applied health
promotion and disease prevention research. The proposed UWPRC will build on and extend the success of the
existing UWPRC. UWPRC will be led by an experienced Administrative Team who engage with a broad base of
academic experts through a Steering Committee and Faculty Advisors Committee. Community consultation and
engagement through the Community Advisory Board and the Translational Partners Panel, enable high-quality
and community-grounded intervention, implementation, and public health practice-based research and
translation. The UWPRC will be housed in the School of Medicine and Public Health, a medical school that
integrates public health in its research, teaching, and service missions and is integral to Wisconsin’s public health
system. The core research project, “Community-based health promotion and prevention modifying Staying
Healthy After (Around) Childbirth (STAC) for birthing persons at risk for and with hypertension during
pregnancy through postpartum” is a dissemination and implementation project to adapt STAC, an evidence-
based intervention for remote blood pressure monitoring for hypertension disorders in pregnancy (chronic
disease priority category 5). The project goals are to initiate remote hypertension care during pregnancy and
through six-weeks postpartum and incorporate implementation of the program in community-based
organizations through a community-engaged participatory approach to improve identification, prompt treatment,
in Black persons at risk for or with hypertensive disorders in pregnancy. The project will build relationships with
community-based organizations led by Black women and those serving Black women, and address gaps in
scalability and identification of necessary supports for adoption and implementation of the intervention. The
UWPRC will continue and expand its participation in the PRC Network throughout the funding cycle. We are
uniquely positioned to develop, test, and translate evidence-based strategies at the interface of communities,
public health, and health care, where translational barriers often delay or prevent their impact.

Public health relevance
PROJECT NARRATIVE The overarching mission of the University of Wisconsin-Madison Prevention Research Center (UWPRC) is to improve the health of women and birthing people, infants, and families impacted by health inequities, by conducting and building capacity for high-quality applied health promotion and disease prevention research. The UWPRC will accomplish this by engaging multidisciplinary campus researchers, public health practitioners, community-based and governmental organizations, and families to develop and advance a research and translational agenda. A strong emphasis will be placed on community engagement, consultation, capacity building, and partnership to advance the translation and dissemination agenda.